Manipulating islet GPCR activity to promote beta cell proliferation and survival

Project Summary/Abstract
T2D incidence increases with age, in part due to a decreased ability of β cells to respond
to proliferative cues as they get older. Our lab identified the FoxM1 transcription factor as
a critical regulator of β-cell replication and survival. Foxm1 expression in islets declines
with age in mice and humans, but activation of FoxM1 in older mouse β cells increases β-
cell proliferation and mass. RNA-sequencing revealed that FoxM1 over-expression in β
cells decreases expression of EP3 and increases expression of EP4, two G protein-
coupled prostaglandin E2 (PGE2) receptors. In isolated islets from mouse and human, we
found that pharmacological inhibition of EP3 or activation of EP4 promotes β-cell
proliferation and survival. The current proposal makes use of in vivo mouse models,
human islet transplants and ex vivo islet cultures from humans with normoglycemia and
Type 2 diabetes to determine the downstream signaling pathways that mediate the effects
of inhibiting EP3 or activating EP4. Using phosphoprotein arrays of ex vivo treated mouse
islets, we identified PLCγ and PKA as acting downstream of EP3 inhibition or EP4
activation, respectively. In the current proposal we explore the hyopothesis that EP3
blockade (working through PLCγ) or EP4 activation (working through PKA) will ameliorate
diabetes and enhance human islet transplantation in vivo by increasing insulin secretion,
and enhancing β-cell proliferation and survival. We propose that FoxM1 directly activates
EP4 while repressing EP3 expression. These studies are designed to identify molecular
targets to enhance function, proliferation and survival of β cells with the goal of increasing
functional β cell mass.

Public health relevance
Project Narrative/Relevance Statement The incidence of Type 2 diabetes increases with age, in part due to a decreased ability of older β cells to respond to proliferative cues. We discovered that the EP3 and EP4 prostaglandin E2 (PGE2) receptors reciprocally regulate β-cell proliferation and survival, and that EP3 increases with age. This study makes use of in vivo mouse models as well as ex vivo studies in mouse and human islets to determine whether EP3 inhibition or EP4 activation can prevent or reverse diabetes by enhancing functional β-cell mass and to identify the signaling pathways through which these PGE2 receptors mediate their effects in β cells.